Advancing Precision Oncology with Scalable Software Solutions for Clinical Variant Interpretation and Expert Curation

Project Summary/Abstract
Adam Coffman is a lead software engineer on CIViC, an open access, community-driven web resource for
Clinical Interpretation of Variants in Cancer. CIViC is a critical and integral part of the cancer variant
interpretation ecosystem, and has been integrated into dozens of academic, clinical, and commercial
resources. This application aims to support Mr. Coffman as a Research Software Engineer in the Griffith Lab at
Washington University St. Louis School of Medicine so that he can continue to make significant contributions to
the CIViC platform under the supervision of Dr. Obi Griffith, PhD. Mr. Coffman studied Computer Science as an
undergraduate, has worked as a software developer in industry, and has over a dozen years of experience in
research lab settings developing open source web applications in support of precision oncology and
bioinformatics projects. The three years of funding provided by the Research Software Engineer award would
grant stability and protected time for Mr. Coffman to focus on the CIViC project’s most high priority
development needs. He will build features to help reduce the bottleneck caused by editorial review including
tools commonly requested by the ClinGen Somatic Cancer Variant Curation Expert Panels (SC-VCEPs) such
as dependent task assignment, automated variant coordinate curation, and variant pathogenicity scoring based
on assigned criteria. Additionally, he will build out novel visualization and search tools that fully leverage the
underlying knowledge graph to allow users to explore the data available in CIViC in a more accessible and
intuitive manner. Mr. Coffman will ensure CIViC remains current in implementing emerging data standards for
variant representation developed by the Global Alliance for Genomics and Health (GA4GH) and other relevant
standards bodies. This support will be critical to maintain and improve upon CIViC’s wide adoption and ease of
integration into other resources. Finally, Mr. Coffman will develop new training materials to enable further
community adoption and continue to provide direct support to labs, clinics, and companies integrating CIViC’s
free and open data into their platforms. Over the course of this award, Mr. Coffman expects to build upon his
already extensive experience in web application development by obtaining additional skills in areas such as
data visualization and graph algorithms.

Public health relevance
Project Narrative Adam Coffman is a senior software engineer in the Griffith Lab at the Washington University in St. Louis School of Medicine and he has extensive experience leading the development of multiple widely used, open source, bioinformatics web applications. The funding support from this award will allow him to dedicate at least half of his time to improving The Clinical Interpretation of Variants in Cancer (CIViC) knowledgebase. These improvements will address critical areas of need for the knowledgebase including alleviating editorial bottlenecks, supporting emerging data standards from ClinGen and The Global Alliance for Genomics and Health, and making the data more accessible through visualization and graph-based search capabilities.